Role of the Epicardium in Valve Development and Valve Disease

In this project we aim to determine the role of epicardially-derived cells (EPDCs) in the formation
of the atrioventricular (AV) valves and to investigate their potential role in the pathogenesis of
myxomatous valve disease (MVD). A few years ago, we published a study in which we described
how EPDCs at the atrioventricular (AV) junction contribute to a specific set of leaflets of the AV
valves. To obtain insight into how these events are regulated, we initially focused on growth factor
signaling through the Bone Morphogenetic Protein (BMP) pathway. We deleted the BMP receptor
ALK3/BMPR1A from the epicardial cell lineage using the epicardial-specific WT1cre mouse. We
observed that this led to abnormalities at the AV junction, including a significant decrease in the
number of AV-EPDCs in the lateral valve leaflets. We also found that, after birth, the valves
developed a myxomatous valve phenotype, reminiscent of that being observed in patients
suffering MVD. Deleting the transcription factor SOX9 from the epicardial cell lineage led to similar
results. The goals of this project are to determine the mechanisms regulating the migration of AV-
EPDCs into the parietal AV valve leaflet, to establish how AV-EPDCs regulate AV valve
development, and to elucidate their role in the pathogenesis of mitral valve disease.

Public health relevance
Recent studies in the mouse have shown that during development, epicardially-derived cells (EPDCs) contribute to the formation of the atrioventricular valves. When this process is perturbed, mice develop abnormal valves, that are very similar to those seen in humans with Myxomatous Valve Disease (MVD). Increasing our insight into how EPDCs contribute to the developing valves in health and disease may further our understanding of the pathogenesis of valve disease in humans.